Flow Cytometry Shared Resource

PROJECT SUMMARY: FLOW CYTOMETRY SHARED RESOURCE
The UNMC Flow Cytometry Research Facility (FCRF) is a fee-for-service flow cytometry shared resources
laboratory providing research flow cytometry services to investigators in the Buffet Cancer Center (BCC), as
well as the UNMC campus and other regional academic and corporate clients. The goal of the FCRF is to be a
valued research partner by providing access to state-of-the-art instrumentation, scientific and technical
expertise, and comprehensive flow cytometry support to all investigators. Currently, the FCRF supports two
multicolor FACSAria cell sorters with 14 simultaneous fluorescent parameter capabilities, one of which is
contained within a class 2A biological safety cabinet. Furthermore, magnetic cell separation services are
provided using a Miltenyi AutoMACS Pro magnetic cell separator. In addition to cell sorting, the FCRF provides
access to a suite of analytical cytometers, ranging from two analog analysis instruments with exceptional low-
end resolution, ideal for DNA synthesis measurements, to two high-end, multi-laser and multi-parameter flow
cytometers with 14- and 18- simultaneous fluorescent parameters. Also, the facility supports a pioneering high
content, 9-laser, 30-parameter (upgradable to 50 parameters) Fortessa X50 flow cytometer providing access
for UNMC investigators to high content flow cytometry capabilities. All three high-end analyzers are equipped
with a high throughput system for automation of sample analysis in 96-well plates. Aside from providing access
to a range of advanced flow cytometry instrumentation, the FCRF provides support in all areas of established
protocols and development of new applications guided by investigator needs. In addition, the FCRF provides
all necessary training and education to allow UNMC investigators and staff to have a solid base in flow
cytometry knowledge and principles, successfully prepare samples for analysis and sorting, and self-operate
FCRF instrumentation with confidence and competence. Overall, the FCRF continuously strives to be a valued
research partner by providing UNMC investigators with the flow cytometry resources they need to successfully
design, prepare, acquire, analyze, and present flow cytometry data.